Research Training in Pediatric Infectious Diseases

ABSTRACT
The goal of the proposed training program is to continue to provide tailored, strong research skills and
knowledge in the discipline of Pediatric Infectious Diseases for physician-scientists pursuing a career in
academic Pediatrics. Our proposed training program is multidisciplinary, combining resources and faculty from
multiple departments of the Johns Hopkins University School of Medicine and Bloomberg School of Public
Health, who share an interest in mentoring and promoting biomedical research to young physician
investigators. American Board of Pediatrics-eligible or certified post-doctoral trainees with a MD (or equivalent)
or MD-PhD, have the opportunity to receive training in basic or clinical research in Pediatric Infectious
Diseases. Twenty nine program faculty (including the Program Director), 17 primarily in basic science
investigation and 12 in clinical investigation have been selected for the strength of their research programs,
prior experience in training biomedical scientists and their extramural research support. Our program faculty
comprise 21 full Professors, four Associate Professors and four Assistant Professors, as well as Mentors-in-
Development, who meet the selection criteria and possess strong potential. Postdoctoral candidate selection is
based upon commitment to an academic career. Research training utilizes individual development plans;
tailored coursework and seminars with training in clinical Pediatric Infectious Diseases; participation in clinical
and research conferences; preparation of manuscripts, grant writing, and scientific presentation skills; training
in diversity, equity, and inclusion; and training in the responsible conduct of research. Since the inception of
this training grant in 2002, all 22 graduates are currently active members of Pediatric Infectious Diseases
programs at academic institutions (Johns Hopkins University, University of Maryland, University of Texas
Southwestern, Children's Hospital of Philadelphia) or in government settings (NIH, FDA, CDC). The success of
our Pediatric Infectious Diseases Fellowship program is exemplified by our trainees' acquisition of extramural
funding as principal investigators (PI): one current trainee received the Pediatric Scientist Development
Program award; of the graduated trainees, six received a NIH K23/K08 Mentored Research Career
Development Award, two received NIH K24 grants, four received one or more NIH R03/R21 grants, one
received the NIH Director's Innovator Award, four have received one or more NIH R01/U01 grants, and two
have received U19 grants. Since its inception, our program has also been successful in recruiting highly
competitive under-represented minorities in medicine (25%) and female trainees (61%). Therefore, we have an
outstanding track-record of recruiting diverse applicants and producing physician-scientists who are committed
to careers in academic Pediatric Infectious Diseases and biomedical research. Based on our research
program, resources, and accomplishments, we are requesting support for four postdoctoral training positions.

Public health relevance
NARRATIVE We propose to provide research training in Pediatric Infectious Diseases. Graduates of our training program will have a significant impact on the Pediatric Infectious Diseases-related research needs and workforce of the nation.